Origins and Outcomes of Smartphone and Social Media Habits Across Development

PROJECT SUMMARY
With widespread public concern about the increasing presence of smartphone and social media (SSM)
technologies in the lives of American youth,1–3 there is a conspicuous need for investment in rigorous scientific
work that will inform our understanding of the psychological precursors of SSM habits, and on the impacts that
these habits may have on subsequent development and everyday functioning. While a foundational literature is
starting to form, research on the origins and outcomes of SSM habits remains skeletal, and two basic
questions are still unanswered: 1) Are the correlates of digital media habits stable across development, or do
they vary with age? 2) In what direction do these relationships ensue – do observed correlations reflect
individual differences that presage subsequent variation in SSM habit formation/intensity, or, do they reflect the
impacts of SSM habits on consequent brain/psychological development and everyday functioning? The
present study aims to refine our answers to these key questions through a multi-methodological (behavior,
neuroimaging, self-reports, ecological momentary assessment) cross-sequential investigation of the individual
differences factors that prospectively predict SSM habit formation and of the outcomes associated with
intensification of such habits across development. Through an initial cross-sectional assay of children,
adolescents, and young adults, we will investigate whether the relations between psychological/brain
functioning and SSM behaviors vary as a function of age. In a subsequent longitudinal phase, we will
concurrently track trajectories of psychological/brain maturation, everyday functioning (e.g., academic
outcomes, psychological and physical wellbeing), and SSM engagement, in order to shed light on the temporal
chain of processes linking mental functioning and SSM usage. Our investigative team is extremely well
positioned to execute the proposed research, which will draw heavily from the theoretical framing and methods that
have propelled our previous work, and which will recruit from active developmental cohorts who have participated in
related recent studies implemented in our labs. Based on guiding neurodevelopmental theories, we hypothesize
that individual differences in self-regulatory control, reward and sensation seeking, reactivity to social inputs,
and risk-taking propensity will be differentially predictive of usage patterns at varying points in development,
and that these relationships will be shown to have bidirectional interactions with intensifying SSM behaviors,
with important implications for everyday functioning.

Public health relevance
PROJECT NARRATIVE The emergence of new technology/media forms has often been accompanied by panic over the likely societal and personal harms they might engender, especially with respect to developing youth. The proposed project seeks to inform our understanding of the particular precursors, correlates, and sequelae that may be linked to the escalating presence of smartphone and social media technologies in teens' lives, and to guide us in determining when these technology habits should, and should not, concern policy-makers and care-givers. The project will enact a multi-methodological cross-sequential longitudinal study to investigate the psychological and brain factors that predispose individuals of different ages to intensified use of smartphones and social media (SSM), and to explore the relationship that such habits may have with specific aspects of cognitive and brain development, psychosocial maturation, and everyday functioning.